NCANDA: Data Analysis Resource

PROJECT SUMMARY
Excessive alcohol drinking Initiated during adolescence is known to disturb typical neurodevelopmental
patterns, increase the risk of developing alcohol use disorder (AUD), and accelerate involutional processes in
adulthood. In response to RFA-AA-21-009, the Data Analysis Resource (DAR) proposes to support the next 5
years' data collection and analysis across a diverse community sample of male and female participants that
were recruited in 3 age bands between 12 and 21 years old, were mostly no-to-low drinkers, and tracked over
the last 8 years across 5 sites (N=831; 93% retention rate). Monitoring has involved annually-acquired
multimodal neuroimaging (MRI, DTI, resting state fMRI, task fMRI) and cognitive, clinical, behavioral, and
biological data, collected in person or remotely by computer and our mobile app. These measures will now be
complemented with new advanced neuroimaging and sleep and physical activity tracking. This cohort
sequential design uniquely positions NCANDA-A to quantify transient or enduring alcohol-related disturbances
in specific adolescent and early adult neural system growth trajectories and functional concomitants.
NCANDA-A proposes four consortium-wide specific aims and two specialty project aims. In Aim 1, NCANDA-A
will investigate the impact of excessive alcohol drinking during adolescence and emerging adulthood on
subsequent developmental trajectories of cognitive performance, brain structure and function, and
psychopathology. Aim 2 analyses will identify neurodevelopment patterns describing the extent to which
alcohol’s effects on brain structure and function resolve or persist during desistance after binge drinking. Aim 3
will deploy data-driven analysis to identify adolescent biological, environmental, and behavioral factors (e.g.,
age of drinking onset) that forecast excessive drinking during early adulthood. In Aim 4, NCANDA-A will
quantify the impact of the COVID pandemic on life stress and social, emotional, and economic wellbeing and
their relations with alcohol use patterns. For each aim, sex differences in development, alcohol use patterns
and history, impact of alcohol use on the brain, and sex-differentiating psychosocial factors will be tested.
The goal of the DAR is to support hypothesis testing based on five aims. Aim D1 will ensure that procedures
for collection and quality control of neuroimaging, neuropsychological, and clinical assessment data are
standardized. In Aim D2, the DAR will advance the existing informatics infrastructure for integrating data
collected across all sites. Aim D3 will enhance macrostructural, microstructural, and functional neuroimage
processing and analysis. In Aim D4, the DAR will create machine (deep) learning frameworks identifying
predictive markers of early adulthood drinking. Aim D5 will maintain data sharing and distribution systems for
consortium PIs and the scientific public at large.
With the longitudinal data collected into early adulthood during this renewal, NCANDA-A will provide novel
information to the public on the enduring and transient effects of adolescent drinking on adult functioning.

Public health relevance
PROJECT NARRATIVE Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA-A (Adulthood) is to follow youth who have and have not engaged in hazardous drinking to determine alcohol's influence on the brain, cognition, emotion, and life activities in emerging adulthood when young men and women are establishing themselves in careers, relationships, and independent living. Recognition of signs of risk to adjustment in adulthood following youthful drinking may enhance opportunity for personal success.